2025 Molecular and Cellular Biology of Lipids Gordon Research Conference and Gordon Research Seminar

Lipids play a pivotal role in nearly all aspects of cellular function, including cell membrane construction, energy metabolism, hormone synthesis, nutrient transport, and regulation of the inflammatory response. Underscoring their importance, perturbation of lipid metabolism leads to cardiovascular disease, metabolic syndrome, obesity, and numerous other disorders that constitute a key focus of the NHLBI mission. Innovative research to elucidate the unique functions of lipids and mechanisms that regulate their synthesis will continue to discover new pathological mechanisms and potential treatments for these disorders.
The Molecular and Cellular Biology of Lipids (MCBL) Gordon Research Conference continues to be the premier meeting in the lipid research field. It provides a forum for networking, collaboration, and the dissemination of new, predominantly unpublished research findings and breakthrough analytical tools in the fields of lipid biology, biochemistry, and biophysics. The 2025 MCBL Gordon Conference will place a particular focus on “Re-Envisioning the Fluid Mosaic Model of Membrane-Lipid Interactions with Cutting Edge Approaches.” The fluid mosaic model revolutionized our understanding of membrane-lipid interactions when it was proposed about 50 years ago. While the fundamental structure proposed by this model remains valid, re-envisioning the model in light of the wealth of knowledge made possible by new analytical tools is essential to advance our understanding of the role of membrane lipids in cellular function. The 2025 MCBL will incorporate and build on the major successful strategies of previous meetings to explore this unique focus. The specific aims of this meeting are to: 1) present unpublished exciting interdisciplinary data that highlight emerging concepts and hypotheses in lipid research; 2) disseminate knowledge about cutting-edge tools and approaches; and 3) provide an exciting environment that encourages the free exchange of ideas among researchers at all career levels.
The anticipated impact of this meeting will be: 1) the dissemination of the latest discoveries that fine-tune the fluid-mosaic model and the exciting new approaches that will continue to advance lipid research, and 2) the generation of new relationships and collaborations among junior and senior scientists that fulfill the NHLBI mission to further develop, and sustain a scientific workforce committed to lipid research.

Public health relevance
Understanding the pivotal role of lipids in cell function and the consequences of perturbation of lipid metabolism is key to discovering the pathogenic mechanisms and potential treatments for cardiovascular disease, metabolic syndrome, obesity, and numerous other disorders. The focus of the 2025 Molecular and Cellular Biology of Lipids Gordon Research Conference on “Re-Envisioning the Fluid Mosaic Model of Membrane-Lipid Interactions with Cutting Edge Approaches” will guide the presentation of emerging concepts and hypotheses as well as cutting edge tools and approaches that drive innovation in lipid research. The meeting will provide an exciting environment that encourages the free exchange of ideas among researchers at all career levels.